Molecular determinants and function of axonal actin assemblies

The overall goal of this application is to clarify the molecular organization and function of enigmatic axonal actin
assemblies that my lab recently discovered. Actin organization along axon shafts has been relatively ignored for
decades, probably because routine staining – using the classic actin-filament marker phalloidin – only shows a
patchy, uninteresting pattern. However, recent studies from us and others' using super-resolution microscopy
and low-light imaging have revealed a hidden world of actin in axon shafts – replete with elaborate circumferential
rings underneath the plasma membrane, and rapidly elongating linear filaments along the axis of the axon shaft.
We have been fortunate to be at the forefront of these discoveries, and our studies have revealed fascinating
actin dynamics in axons. Specifically, we found that axons have focal “hotspots” of actin – spaced ~ 3-4 µm apart
– where actin continuously polymerizes and depolymerizes. These hotspots give rise to long actin filaments that
rapidly (and bidirectionally) elongate along the axon shaft (we named these “actin trails”). Actin rings, trails and
hotspots are seen in axons in vivo, and we will use in vivo model systems in this proposal as well. Although the
overall assemblies have been seen, molecular events underlying the generation and maintenance of these
structures is unclear. Importantly, their functional roles in axons are unknown. Here we propose three specific
aims to clarify the organization and function of these newly-discovered actin assemblies: Aim #1: Identify
mechanisms initiating actin trails in axons. Aim #2: Identify mechanisms elongating actin trails in axons. Aim
#3: Determine functions of axonal actin assemblies.

Public health relevance
Actin is a highly conserved protein and an integral component of the cytoskeleton – involved in numerous physiologic activities, as well as in many neurodevelopmental and neurodegenerative diseases; particularly autism. Using probes that selectively report actin filaments and advanced microscopy techniques that allow visualization of sub-diffraction structures, we discovered previously unknown actin assemblies along the shafts of axons. The goal of the proposed experiments is to dissect the molecular mechanisms underlying these axonal actin assemblies, and also learn what their functions are.